Understanding components of mind-body exercise for physical activity engagement in metabolic syndrome

PROJECT SUMMARY
This K23 award will support the candidate’s training and development for an independent clinical research
career focused on understanding mechanisms of mind-body exercise interventions to optimize them for health
behavior promotion in medical populations. BACKGROUND. Rates of physical inactivity are alarmingly high,
particularly in patients with cardiometabolic conditions. Mind-body exercise interventions are promising for
promoting physical activity because they engage key health behavior change processes. While the
multidimensionality of mind-body exercise interventions is a strength, it also poses challenges for
understanding how individual therapeutic components engage health behavior change processes.
Disentangling the relative contribution of therapeutic components is critical for optimizing mind-body exercise
interventions for physical activity promotion. SPECIFIC AIMS. Using metabolic syndrome as a model, the
proposed study aims to: (1) refine the content and procedures of a factorial design to dismantle two mind-body
exercise components, exercise and mindful attention, via feedback from focus groups with sedentary patients
with metabolic syndrome and an interdisciplinary expert panel; (2) evaluate the feasibility and acceptability of
the factorial design in a pilot RCT; and (3) explore within-group patterns of change in self-regulation,
cardiopulmonary physiology, and physical activity levels across three timepoints. TRAINING. The candidate
will receive training in three areas to develop expertise critical to her overall career goals: (1) optimization-
focused clinical trial design and implementation; (2) qualitative research and longitudinal data analysis
(mediation); and (3) cardiopulmonary physiology research. These training aims will be supported by vast
institutional resources, as well as coursework, trainings, research seminars/meetings, and scientific
conferences. MENTORSHIP. The candidate will be supported by an expert mentoring team: Gloria Yeh, MD,
MPH (primary mentor), Peter Wayne, PhD (co-mentor), Long Ngo, PhD (collaborator), Chung-Kang Peng, PhD
(collaborator), Daniel Forman, MD (consultant), Erick Loucks, PhD (consultant), and Karen Kilgore, PhD
(consultant). IMPACT. In line with NCCIH priorities, skills acquired through this K23 proposal will promote an
independent research career focused on understanding how mind-body exercise interventions promote health
and optimizing these interventions to foster health promotion. While initial studies will focus on metabolic
syndrome and physical activity engagement, findings from this project will allow the candidate to develop a
model to study mind-body exercise for other medical populations known to struggle with initiating and
sustaining healthy behaviors. This K23 award will provide preliminary data for a R61/R33 application to
examine relative contributions of mind-body exercise components on health behavior change processes and
whether changes in these processes lead to downstream improvements in physical activity engagement.

Public health relevance
PROJECT NARRATIVE Physical inactivity is prevalent, costly, and deadly, particularly among individuals with cardiometabolic conditions. While mind-body exercise interventions (e.g., yoga, tai chi), which include several therapeutic components (e.g., physical exercise, mindful attention), are promising for improving physical activity levels, it is difficult to optimize these interventions for physical activity promotion without understanding the effects of these core components on health behavior change processes. Using metabolic syndrome as a model, this project will assess the feasibility and acceptability of a factorial design that examines the effects of two mind-body exercise components, exercise and mindful attention, on key health behavior change processes.